Clinical and Preclinical Models in Drug Abuse: Training and Development

DESCRIPTION (provided by applicant): The purpose of this Senior Scientist Research and Mentorship Award (K05) application is to allow me (Richard W. Foltin, Ph.D.) protected time so that I may continue to mentor junior faculty. In this way I will share with the junior faculty much of what I learned from my mentors and in turn have my research benefit from what I learn from the junior faculty. Specifically, I will share my experience in conducting well-controlled, laboratory- based studies in areas that are difficult to model (relapse, putative medication effects on drug self- administration, estimating reinforcing values of behavior) with junior colleagues who are hoping to bring similar powerful methodologies to bear on their areas of expertise. Goal 1. Research: Aim 1. Maintain active research programs using laboratory models of drug abuse in non-human primates and drug-experienced human volunteers. My active support has always played a role in providing both research opportunities and salary support for junior faculty. I have 2 active R01s and 2 pending R01 submissions that will be used to support my research and provide training opportunities. Aim 2. Expand my research interests by incorporating the expertise of junior faculty I am mentoring in neuropsychology, magnetic resonance imaging, eating disorders and geriatric psychiatry. Goal 2. Training: Aim 1. Continue to be a valuable resource to the more senior faculty in our research group whom I have mentored since they completed their postdoctoral fellowships. Aim 2. Help the individuals whom I mentored on their K awards who are in their 4th and 5th years and now transitioning to independent status. Aim 3. Provide guidance to the individuals whom I mentor that are in the first several years of their K awards. Aim 4. Keep a discernible profile in departmental affairs so that I can be an advocate for drug abuse research and the needs of junior faculty. I have sufficient mentoring responsibilities to account for my mentoring effort over the next 5 years. Generally the junior faculty I mentor will first conduct projects that will be funded as part of one of my R01s, and then apply for divisional funds for pilot studies where possible prior to submitting a K application. This model has worked well in the past and will be used to develop new K awards for junior faculty.

Public health relevance
The purpose of this Senior Scientist Research and Mentorship Award (K05) application is to allow me (Richard W. Foltin, Ph.D.) protected time so that I may continue to mentor junior faculty. I will share my experience in conducting well-controlled, laboratory-based studies in areas that are difficult to model (relapse, putative medication effects on drug self-administration, estimating reinforcing values of behavior) with junior colleagues who are hoping to bring similar powerful methodologies to bear on their areas of expertise.